Antigenic and virological traits of HIV-1 breakthrough infections in the VRC01 antibody-mediated prevention Phase 2b trial in sub-Saharan Africa

PROJECT SUMMARY
Whether through active or passive immunization, broadly neutralizing antibodies (bNAbs) will likely form
a cornerstone of HIV prevention. This application proposes an ancillary study of the African component of the
antibody-mediated prevention trial (AMP) (HVTN 703/HPTN 081). The AMP study is the first proof-of-concept
trial to evaluate the safety and efficacy of a bNAb (VRC01) to block HIV acquisition. Our team is involved in the
laboratory investigations to measure serum levels associated with protection, and through sieve analysis, to
determine how predicted genotypic features correlate with prevention efficacy. The goal of this application is
to provide a deeper understanding on how HIV-1 diversity affects the amount of antibody needed to
prevent infection; and the clinical consequences of infection with VRC01-resistant viruses.
The extreme diversity of circulating HIV strains, together with the flexibility of the Envelope protein (Env)
in evading immune pressure, could threaten the effectiveness of immunization studies. Utilizing sequence data
and functional env clones from AMP breakthrough infections, the first aim will provide an up-to-date bNAb
sensitivity profile of circulating strains, providing data useful for future clinical trials. This analysis will be done
using the standardized Env-pseudotyped assay, and a subset will also be evaluated using infectious env clones
generated in PBMCs to verify these data. The parent protocol sieve analysis will predict genetic features that
affect VRC01 neutralization susceptibility and resistance, and the second aim of this application will
experimentally validate these predictions, as well as evaluate how the cognate Env of breakthrough infections
influences the impact of these mutations. This will provide experimental data on how changes in envelope affect
the amount of antibody needed for prevention of infection. Lastly, VRC01 escape mutations have been
associated with reduced viral fitness and we will compare fitness of VRC01-resistant and sensitive viruses and
determine how this affects key clinical markers such as HIV viral load and CD4 counts.
The HVTN 703/HPTN 081 trial provides a unique opportunity to define the impact of diversity on bNAb
efficacy in a sub-Saharan Africa setting where new prevention approaches are still urgently needed. This study
will be led by investigators at the University of Cape Town and the Fred Hutchinson Cancer Research Center,
in collaboration with the National Institute for Communicable Diseases, and includes a training partnership with
North-West University in Mahikeng, South Africa. Information generated in this proposal will support the next
phase of combination passive immunization trials and will provide seminal data to understand the prevention
efficacy of VRC01.

Public health relevance
Narrative: Despite the discovery of new prevention tools, and the expansion of treatment, HIV-1 continues to spread. With no effective HIV-1 vaccine available, the passive administration of broadly neutralizing antibodies (bNAbs) for prevention is a promising alternative. This project aims to utilize samples from the first proof-of- concept antibody-mediated prevention (AMP) study in Africa to gain a deeper understanding of how HIV-1 diversity might affect prevention efficacy and to determine the clinical consequences of infection with bNAb resistant viruses.